Dopaminergic and Muscarinic Signaling in the Striatum

Summary:
Parkinson’s disease (PD) is the second most common neurodegenerative disease in world and incidence of the
disease is expected to steadily rise. Levodopa therapy has been the standard treatment strategy for PD patients
for nearly 60 years and while it is effective in alleviating many motor symptoms in the early stages of PD, I it is
plagued by the induction of dyskinesia is late stage patients. Hence, there is a major medical need for 1)
symptomatic therapies that do not have the side-effect profile of levodopa and 2) better therapeutic strategies
for alleviating LID. Our central thesis is that striatal cholinergic interneurons (ChIs) are pivotal
determinants of the striatal pathophysiology underlying both PD motor symptoms and LID –
making them prime targets for the development of new therapies. While it has long been appreciated
that aberrant striatal cholinergic signaling is a contributing factor in the motor symptoms of PD, the mechanisms
underlying this linkage have not been fully delineated. The mechanisms underlying LID are even less well
understood. Current thinking has focused upon the direct actions of levodopa-derived dopamine (DA) on the
principal neurons of the striatum. However, several lines of evidence, including new results presented in this
application, suggest that a particular class of interneuron that releases acetylcholine is not just important, but
necessary for LID. Moreover, our preliminary studies provide a mechanistic foundation for this observation,
suggesting that alterations in the properties of principal neurons actually trigger aberrant activity in interneurons
– reconciling the two apparently discrepant scientific perspectives. In addition, our preliminary work establishes
the importance of interneuron-dependent, striatal remodeling not only when striatal DA levels are high (so-
called on-state), but also when DA levels are low and movement is so difficult (off-state). Far from being a passive
period, the striatal circuitry is being distorted during this period, contributing to the severity of the dyskinesia
during the next on-state. Indeed, an FDA-approved and well-tolerated drug when administered during the off-
state significantly alleviates LID in a mouse model. But much remains to be done if these exciting new discoveries
are to be translated into new treatments for PD patients. We propose to take advantage of a collection of new
tools to pursue four specific aims in rodent models: 1) characterize the determinants of ChI activity and
ACh release in PD and LID states; 2) characterize how ChI activity directly modulates SPNs in
PD and LID states; 3) characterize how ChI activity indirectly modulates SPNs through
intrastriatal GABAergic networks in LID states; 4) characterize how ChI activity remodels the
functional connectomes of SPNs in PD and LID states. Although these aims are ambitious and beyond
the reach of a modular R01, they are within the grasp of the outstanding, interactive team we have assembled for
this non-modular proposal – putting novel therapies for PD patients on the event horizon.

Public health relevance
Narrative: Parkinson’s disease (PD) is the second most common neurodegenerative disease in world, but current symptomatic therapies are of limited value and have unwanted side-effects. Through the use of new genetic tools to manipulate and monitor the function of neurons in the brain regions responsible for PD, we have found that a particular type of neuron plays a pivotal role in both the core motor symptoms of PD and dyskinetic side-effects of the gold standard treatment for PD – levodopa. The proposed studies will build upon this discovery to forge a better understanding the cellular and molecular mechanisms underlying PD in the hope that this will lead us to new symptomatic therapies that are more effective and less burdened by side-effects.